Home-Based Community Health Worker Support for Mental Health among People Living with HIV: A Hybrid Effectiveness Implementation Trial

PROJECT SUMMARY. South Africa (SA) is home to the largest number globally of people with HIV (PWH).
Mental health (MH) conditions, particularly depression and harmful alcohol use, are non-communicable diseases
contributing greatly to HIV morbidity and mortality in SA due to poorer quality of life, lower engagement in HIV
care, and worse disease progression. A key priority of SA Department of Health is to integrate MH services into
an existing infrastructure of community health workers (CHWs) conducting home visits to engage PWH who are
initiating or re-initiating HIV treatment. CHWs often encounter patients with MH, yet receive little MH training
despite interest. Training CHWs in an evidence-based intervention to support PWH with MH concerns is a unique
opportunity to improve HIV and MH outcomes. Guided by the ADAPT-ITT model for intervention adaptation and
the Consolidated Framework for Implementation Research (CFIR), this proposal builds upon our prior work that
developed clinic-based interventions for PWH to support MH and HIV care outcomes based on motivational
interviewing, problem solving, and behavioral activation, and aims to adapt the approach and implementation
strategies for home-delivery (“Khanya-Ekhaya”). We are leveraging a robust, existing infrastructure of CHWs
doing home visits with PWH, thus promoting the sustainability of the proposed model. We propose to: (1) Explore
multi-level barriers and facilitators to implementing a home-based CHW intervention (Khanya-Ekhaya) for PWH
with MH concerns seen by a CHW after newly initiating or re-initiating ART. Guided by CFIR, we will conduct
individual semi-structured interviews with CHWs (n=10), patients (n=30) and other key stakeholders (i.e.,
supervisors, policymakers, organizational leaders; n=10) to inform the adaptation and implementation strategy of
Khanya-Ekhaya for home-based delivery for PWH with MH problems (depression/harmful alcohol use); (2) Adapt
Khanya-Ekhaya for home-based, CHW delivery to improve HIV care engagement and MH symptoms based on
Aim 1, guided by the ADAPT-ITT model and human-centered design principles. We will conduct four workshops
with PWH with depression and/or harmful alcohol use (n=12) and CHWs (n=12) to identify adaptations to improve
acceptability; (3) Evaluate the implementation and preliminary effectiveness of the home-based Khanya-Ekhaya
CHW intervention in a pilot Type 1 hybrid effectiveness-implementation trial (n=20 CHWs), evaluating
implementation outcomes (feasibility, acceptability, fidelity), and preliminary effects on HIV care engagement and
MH symptoms (depression, harmful alcohol use). Implementation outcomes will be assessed among CHWs (n=10)
and patients (n=25) using mixed methods. This proposal is responsive to PAR-23-191 as an innovative
implementation science trial to support MH services shifting from clinic- to community-based care. Capacity
building efforts will build a research network focused on MH and HIV clinical research in sub-Saharan Africa.
Findings will inform an R01 to evaluate effectiveness and implementation of the CHW Khanya-Ekhaya intervention
to reduce MH problems and improve HIV care engagement for PWH with MH concerns.

Public health relevance
Project Narrative South Africa (SA) is home to the largest number of people with HIV (PWH) in the world. Community Health Worker (CHW) programs have been rolled out to improve HIV care engagement in SA, yet mental health (MH) conditions, particularly depression and harmful alcohol use, are prevalent non-communicable diseases that remain significant barriers to care engagement, which CHWs often lack training for addressing. This study will develop home-based CHW training program to improve HIV care engagement among patients with common MH challenges and understand how to shift clinic-based interventions to home-based delivery.